Multi-Domain Sensory Measures as Biomarkers of Alzheimer's Disease in Preclinical and Prodromal Stages

PROJECT ABSTRACT
Sensitive, practical, and non-invasive methods to identify Alzheimer's disease (AD) in preclinical and
prodromal stages are desperately needed to improve patient care by identifying those to target with therapeutic
and/or lifestyle interventions. Cutting-edge clinical trials of anti-amyloid therapies in amyloid-positive older
adults and prodromal AD patients and future trials of anti-tau therapies have the potential to lead to new
treatments targeting AD pathophysiology in preclinical stages. Thus, there is a critical need to develop new
sensitive and readily accessible biomarkers to detect AD-related pathophysiology before marked clinical
decline. Recent data suggest subtle impairments in sensory function, including vision, olfaction, and hearing,
may occur with and even precede clinically relevant cognitive decline. Measures of sensory function are ideal
screening biomarkers because of their ease of use, non-invasiveness, and low cost. However, changes in
sensory function in very early stages of AD have not been comprehensively investigated with respect to novel
neuroimaging tools. Further, the combination of sensory measures from multiple domains has not been
evaluated in the same participants. These knowledge gaps are an important bottleneck because it prevents the
field from using sensory measures to identify individuals who are most likely to benefit from putative therapies
for AD. Understanding how previously underappreciated sensory dysfunction informs us about amyloid and tau
pathology, neurodegeneration, and brain connectivity in preclinical and prodromal AD will provide integral
knowledge about the nature of these early changes, which has great potential to improve patient care by
facilitating early intervention for AD. Our central hypothesis is that early changes in sensory function in
preclinical and prodromal AD indicate the presence of AD-related neuropathology in the brain and reflect the
initial stages of AD-associated cognitive decline. The aims of this project, in response to PAR-18-519:
“Sensory and motor changes as predictors of preclinical Alzheimer's disease,” are to: [1] Test the hypothesis
that changes in visual, olfactory, and auditory measures in preclinical and prodromal stages of AD is driven by
cerebral amyloid and tau deposition and/or neurodegeneration; [2] Test the hypothesis that altered brain
connectivity within sensory networks is associated with measures of multi-sensory function in preclinical and
prodromal AD; [3] Determine whether a combination of sensory biomarkers provides a better prediction of
cerebral amyloid and tau deposition, neurodegeneration, and changes in connectivity than a single measure
alone in preclinical and prodromal AD; [4] Evaluate the ability of cross-sectional and longitudinal sensory
measures to predict future decline in cognition, clinical conversion, and brain atrophy rate. Successful
completion of these aims has the potential to alter the current concepts and methodologies of early diagnosis,
which in turn will support the development of sensory measures as accessible and cost-effective diagnostic
markers for use in screening, diagnosis, clinical trials of AD therapies, and ultimately, treatment.
2

Public health relevance
PROJECT NARRATIVE Non-invasive and inexpensive biomarkers for Alzheimer's disease (AD) that are sensitive to pathophysiological changes in preclinical and early prodromal stages are desperately needed for clinical research, diagnosis and screening, as well as for clinical trials of potential therapeutic treatments. Many researchers believe that effective AD treatments will need to be administered in the earliest preclinical and prodromal stages of disease. Thus, the goal of this project is to understand the pathophysiology of multi-modal sensory changes in preclinical and prodromal AD and to establish measures of sensory function as sensitive screening biomarkers for AD, which can be expected to have great impact on the diagnosis and treatment of AD in early stages of disease.